Vision Science Training Program: Cornea to Cortex

Abstract
The Vision Science Training Program: “Cornea to Cortex” at UC Davis seeks 5 predoctoral
training positions to broaden the skills and research perspective of the future biomedical and
academic workforce by providing specialized training in the mechanistic bases of vision and
related diseases. The training environment includes 32 faculty vision researchers (24
Preceptors and 8 Affiliates) across 8 departments located in 5 different schools/colleges, and it
draws upon the rigorous admission standards and established course structures of the 5
graduate programs of our participating Preceptors. Each of the preceptors has an active
program of vision science research, a demonstrated commitment to training, and strong
extramural funding, with over $15M in annual direct costs (2021-2022). Resources for vision
science training are augmented by a financial and infrastructural institutional commitment, the
UC Davis Center for Visual Sciences, and an NEI Core grant. The program offers unique
training opportunities that include faculty fireside chats, trainee chalk talks, an annual vision
science symposium attended by basic and clinical science faculty and residents, and a two-term
vision survey course that broadly covers basic and clinical visual sciences with contextual
emphases on modern methods, experimental design, biostatistics, and ethics. All trainees will
be engaged in vision science research that will be presented at national meetings and submitted
to peer-reviewed journals. Under the advice and mentorship of their preceptor, trainees will
utilize Individualized Development Plans (IDPs) and annually discuss the IDPs with members of
the Advisory Committee to ensure efficient progress toward employment in their desired niche
within the biomedical workforce.

Public health relevance
Project Narrative This grant will provide support for high quality, specialized training in the mechanistic bases of vision and related diseases with modern approaches to the development of technologies and therapies for eye disease. In addition, this training program will broaden the research perspective, communication skills and knowledge base of future vision scientists. The program is designed to have significant impact on the health and science agendas of the National Eye Institute and to prepare the next generation of PhD scientists to enter the biomedical workforce.